NIH SPARC Annual Meeting 2025

Project Summary
This project will organize and host a two-day meeting for the NIH Stimulating Peripheral
Activity to Relieve Conditions (SPARC) Phase 2 program from March 12-13, 2025. The
meeting will bring together approximately 100 scientists who are working on active
programs funded by SPARC to 1) present recent findings and 2) forge new
collaborations between each other to develop future translational goals for their
projects. The meeting agenda will begin on day 1 with research presentations from
SPARC Phase 2 project teams to showcase their latest activities and discoveries. This
will be followed by a series of workshops that enable different teams to form
collaborations. Day 1 will also include a research poster session that is open to all
attendees and end with research demonstrations. Day 2 will open with presentations
from NIH officials about programs that are aligned with the future work of current
SPARC investigators. Trainee travel award winners will also present their work. Day 2
will also feature rotating roundtable discussions on key issues suggested by SPARC
investigators and report-outs to SPARC program officers.

Public health relevance
This is a supplemental budget request to organize the 2025 SPARC program annual meeting at Case Western Reserve University on March 12-13, 2025. Objective one is the scientific dissemination of current SPARC Phase 2 Projects. Objective two is to help attendees identify future translational activities for these current projects.